Human Cochlear Masking and Suppression Measured using Dynamic Stimuli

PROJECT SUMMARY/ABSTRACT
The healthy auditory system processes and ultimately makes sense of complex dynamic sounds that
vary spectrally and temporally. This complicated process allows for human and non-human species to
communicate in both quiet and noisy environments. Significant advances in the understanding of spatiotemporal
processing has come from human behavioral studies and physiological animal experiments using frequency
sweep stimuli, which are sounds that glide upwards or downwards with frequency over time. Human behavioral
data shows that up-sweeps are substantially more effective at masking a tone compared to down-sweeps (> 20
dB). The behavioral literature attributes the dependence on sweep direction to cochlear dispersion, which
involves variations in the shape of the basilar membrane (BM) waveform generated by each masker. Due to
dispersion, the BM waveform for the down-sweep is peakier compared to the broader response of the up-sweep.
Consequently, the presence of a down-swept masker allows for easier detection of the signal in the dips of its
waveform. This interpretation finds support in animal measurements and physiological models.
While the dispersion mechanism has been used to explain the masking effects between upward and
downward sweeps, recent measurements of cochlear vibration in mouse also reveal differences in the cochlear
suppression produced by upward and downward swept suppressors and these differences are dependent on
sweep rate. Suppression is thought to be important for auditory tasks such as understanding speech in noisy
environments. Similar measures of suppression using up- and down-swept stimuli have not been conducted in
humans, nor have the suppression effects been compared to behavioral masking. Furthermore, although human
behavioral experiments have shown masking differences for upward and downward swept maskers over a range
of sweep rates, none of these studies explored what I hypothesize are perhaps the most interesting range of
rates (i.e., sweep rates similar to the velocity of the BM traveling wave or to frequency transitions in speech).
The proposed aims use a combination of behavioral and otoacoustic measures to study the effects of
sweep rate and direction using swept stimuli as either behavioral maskers or otoacoustic suppressors.
Otoacoustic emissions are advantageous as they provide a powerful, non-invasive measure of outer hair cell
function, enabling the study of suppression effects in humans and their correlation to behavioral masking. The
study will pursue the following aims: 1) Determine the strength of behavioral masking as a function of sweep
rate and direction, and 2) Determine the strength of cochlear suppression as a function of sweep rate
and direction. Completion of the proposed aims will advance understanding of the role of suppression in
processing dynamic sounds that vary in rate and direction. The results may provide a framework for studying
how this process is impacted with impairment, as suppression is greatly reduced with cochlear damage.

Public health relevance
Project Narrative The proposed research examines the role of cochlear suppression in auditory processing of complex dynamic sounds that vary in sweep rate and direction (i.e., frequency sweeps). Key insights on the mechanisms of spatiotemporal processing have come from human behavioral masking experiments and direct physiological recordings in mammals using these stimuli, but cross-species differences and the invasive nature of physiological methods make it challenging to infer function in humans. By leveraging non-invasive otoacoustic and behavioral measures to study cochlear suppression and its dependence on sweep rate and direction, the proposed study will both improve our understanding of cochlear function important for human communication and provide a foundation for understanding how this might be affected by hearing impairment.